Modulation of protein methylation to improve hematopoietic stem cell engraftment

PROJECT SUMMARY:
Expansion of our understanding of hematopoiesis, including identification of key biochemical modulators, is
critical to the development of novel interventions and improved potentially curative procedures such as bone
marrow transplantation. While much study has occurred on the roles of kinases, the hematopoietic roles of the
serine/threonine, multi-subunit PP2A family phosphatases, PP2A and PP4, have only begun to be examined.
PP2Ac is reversibly methylated on its carboxy-terminal leucine (L309) by the methyltransferase, LCMT-1, and
the methylesterase, PME-1, and this methylation regulates formation of certain PP2A complexes, and thus
subcellular targeting and specificity. PP4, which is ~60% identical to PP2A, is also methylated on its carboxyl-
terminal leucine. We recently found LCMT-1 is also the PP4 methyltransferase and selectively regulates
certain PP4 complexes in addition to select PP2A complexes. Through the creation and initial study of a gene-
trap LCMT-1 knockout (KO) mouse and subsequently a pan-hematopoietic conditional knockout (cKO) of the
LCMT-1 allele, we show equally striking reductions in multilineage HSC competitive repopulation activity
despite relatively normal adult HSC homeostasis. Therefore, LCMT-1 may have cell intrinsic roles in promoting
HSC fitness uniquely during the stress at early times post-transplantation. This proposal is a multi-investigator
application that leverages the biochemistry and experimental hematology expertise of both PIs. Together we
have discovered that LCMT-1 plays a critical intrinsic role in hematopoiesis that is specific to HSCs in the post-
transplantation expansion, survival, and self-renewal phase. In contrast, LCMT1 doesn't play a role during
HSC maintenance and cycling during steady-state conditions. Because LCMT-1 substrates are limited to PP2A
family phosphatases due to the unique way LCMT-1 must interact with both specific active site and C-terminal
residues, we hypothesize that LCMT-1 promotes high levels of “methylation-dependent” PP2A and PP4
heterotrimers that in turn modulate key regulatory phosphorylation sites on critical proteins such as Raf to
promote mitogen-associated protein kinase (MAPK) pathway signaling required for the early proliferative drive
during hematopoietic repopulation. In this proposal, we will test this hypothesis and begin dissecting
mechanism by utilizing LCMT-1 cKO mice to define specific defects in adult HSC multilineage repopulating
activity using flow cytometry-based assays. Assays will compare steady-state and replicative stress responses.
The importance of LCMT-1 catalytic activity will be determined, the involvement of methylation-dependent
PP2A complexes in repopulating function will be evaluated, and therapeutic rejuvenation strategies will be
explored. Accomplishing these objectives will move the field forward by improving understanding of signaling
regulation of hematopoiesis and by providing avenues for manipulation of LCMT-1 and PP2A family
phosphatases to accelerate the rate of hematopoietic regeneration.

Public health relevance
Project Narrative Relevance to Public Health: Numerous hematological diseases exist that still lack a clear etiology and/or cure for at least a subset of cases. Expansion of our understanding of hematopoiesis, including identification of key biochemical modulators, is critical for development of novel interventions and improved potentially curative procedures such as bone marrow transplantation. The experiments in this proposal will develop the basis for new biochemical strategies to prevent or treat blood disorders.